Adapting Neurogenetic Technologies for Use in the Desert-dwelling Fly Drosophila Mojavensis

PROJECT SUMMARY:
Our ultimate goal is to elucidate how sensory processing occurs in the brain at the level of individual cells and
circuits, and how this leads to directed behavior through the process of decision making. Here, we will create
neurogenetic reagents that will help introduce the desert fly Drosophila mojavensis as a new comparative
model system to study the neurobiology of temperature and humidity sensing and preference. We will use
CRISPR/Cas9 genome editing technology and site-specific integration to produce D. mojavensis strains that
can be flexibly used to silence, image the activity of, or activate select cell types that process temperature and
humidity signals at the periphery and in the brain. Our expectation is that, once the key foundational work has
been completed, our reagents will help us and others to design powerful comparative studies to establish
conservation and divergence between this extremophile species and its laboratory relative D. melanogaster,
and ultimately help identify general principles used in sensory processing by all animals.

Public health relevance
PROJECT NARRATIVE Our long-term goal is to understand how sensory stimuli are processed in the brain to produce directed behavior. The studies outlined here will help establish the extremophile Drosophila mojavensis as a new neurogenetic model to study sensory responses to external conditions (temperature and humidity). Our expectation is that our reagents will make it possible to design powerful comparative studies, and that increasing the diversity of the model systems we study will help us better extrapolate results obtained in animal studies to the human nervous system, in both normal and disease states.